Role of glia in LRRK2 mediated dopaminergic neuron degeneration

PROJECT SUMMARY
Parkinson's disease (PD) is a neurodegenerative disorder characterized by a progressive loss of dopaminergic
neurons. Currently about one million people live with PD in the United States, and as the risk of developing PD
increases with age and the population of the elderly is increasing, the number of people suffering from this
disease is expected to grow in the future. Developing targeted treatments that slow or halt disease progression
will not only improve patient quality of life, but would also reduce the vast economic burden on society.
LRRK2 G2019S is the most common missense mutation found in PD, and several organisms, including
Drosophila, have been used to model LRRK2-mediated neurodegeneration. LRRK2 G2019S alters neurite
morphology in vitro, and by expressing LRRK2 G2019S in the dopaminergic neurons of flies, we have recently
shown that it induces an age-dependent reduction of neurite length and branching in vivo, prior to overt
neuronal loss. Recent advances in Parkinson's disease research have revealed that PD not only affects
neurons, but also the function of glial cells, rendering them unable to fulfill their physiological role in
maintaining tissue homeostasis and facilitating neuronal transmission. Investigating the precise role phagocytic
glia and astrocytes play in neurite loss and neuronal death is key to fully understanding the mechanisms
leading to neurodegeneration. In Aim 1 of this proposal I will examine whether glial function if altered in aging
mutant LRRK2–expressing flies. In Aim 2 I will evaluate whether inhibiting glial function affects neurite loss,
neuronal death, and motor function across age in LRRK2 G2019S flies, and whether LRRK2 G2019S in the
glia leads to or exacerbates neurodegeneration. In Aim 3 I will examine if morphological changes in neurite
architecture result in functional changes at the synapse, and whether this phenotype is sensitive to glial
activity: I will evaluate the number of synapses across age in LRRK2 G2019S flies, and using a functional
imaging approach determine if neurite loss translates into alterations in synaptic function. The proposed
studies will examine the relationship between neurite morphology, synaptic function, and glial phagocytic
activity, and offer mechanistic insight into the role of glia in pathology. The results will provide a foundation for
future research into novel interventions against PD development and progression.

Public health relevance
PROJECT NARRATIVE Parkinson's disease (PD) is a neurodegenerative disease affecting millions of people globally and there are no therapeutic approaches that can stop or slow down disease progression. Recent research highlights the interaction of glia and neurons as a central mechanism contributing to neurodegeneration, and the advancement in genetic tools and microscopy techniques allows studying disease phenotypes with an exquisite level of detail. The proposed studies seek to examine how neurite defects lead to synaptic dysfunction, and assess the role of glia in PD pathogenesis, with the hope of discovering new therapeutic avenues to manage this devastating disease.